SARS-CoV2 Sequencing Surveillance Program for Upstate South Carolina

Project Summary
The overall objective of this project is to continue and expand surveillance efforts to detect and monitor extant
and emerging variants by sequencing the positive samples detected by the extensive university surveillance and
community testing programs at Clemson University (CU). Variants of concern of SARS-CoV-2 have caused large
outbreak events worldwide. As we tracked during the significant Delta and Omicron outbreaks in Upstate South
Carolina, this poses a serious public health threat; the new variants can escape the coverage of COVID-19
vaccines or infect previously exposed individuals. Our sequencing surveillance program aims to continue to
provide much-needed insight and guidance to inform policy decisions to help mitigate these potential threats.
In response to the COVID-19 pandemic, CU established a robust high-throughput COVID-19 diagnostic testing
program, which enabled the university to remain opened to in-person instruction through most of the pandemic.
The CLIA-certified Clemson Research and Education in Disease Diagnosis and Intervention (REDDI) Lab has
facilitated regular testing of all university personnel and free testing to members of the surrounding Upstate South
Carolina community. The lab has run >10% of all the COVID-19 tests from South Carolina. In 2021, the REDDI
Lab partnered with the CU Genomics and Bioinformatic Facility (CUGBF) to set up a SARS-CoV-2 genomics
sequencing program, which mapped 3 major outbreak events and provided early detection of the Delta and
Omicron variants in the rural Upstate South Carolina region. These data were instrumental to inform the pre-
emptive COVID-19 policies and timely response for the university as well as Upstate SC cities and municipalities.
In addition, the sequencing surveillance program allowed for significant scientific discovery on variant specific
disease presentation, variant differences in effectiveness of vaccine and prior infection protection, surveillance
testing and COVID-19 mitigation strategies, and wastewater community surveillance efforts. The results from
the sequencing program also led to the development of new assays and technologies for COVID-19 diagnosis
and surveillance as well as undergraduate and graduate student training and community outreach programs.
To accomplish our overall goals of continued SARS-CoV-2 genomic surveillance, we propose the following aims:
Aim 1: Determine the association of SARS-CoV-2 genomic variants with population demographics, outbreak
events, COVID-19 symptom severity and duration, previous infection, and vaccination.
Aim 2: Develop real-time workflows and data analytics platforms to meet the challenge of variant surveillance
through the on-going COVID-19 situation for its inevitable transition from pandemic to endemic phase.
Over the last year, we have created a unique and robust sequencing program that not only sequences samples
but also ties the results to a rich university and community COVID-19 surveillance database to enable secure
and effective data mining for continued analysis. Our community testing program has provided testing and
surveillance to remote and underserved areas of the Upstate. This provided for an excellent representation of
the Upstate South Carolina demographics, including significant numbers of patients from populations with known
COVID-19 outcome disparities. Because of the university and our proximity to major travel hubs (e.g.,
Atlanta/Charlotte) there is significant flux of travelers in our area who introduce new variants into our relatively
rural community. Over the past year, we have demonstrated that the SARS-CoV-2 variant prevalence in rural
Upstate SC is distinct from the rest of the state. In addition, our program captured data from patient demographic
groups that are highly under-sampled by other labs at hospitals and public health agencies. The majority of
positive cases detected by our lab were young and usually asymptomatic or minimally symptomatic at the time
of diagnosis. However, we have shown that, particularly with the newer variants of concern, these patients can
readily spread the disease to others and they, themselves, even with mild symptoms, can sometimes have longer
lasting health effects. Overall, this has demonstrated the need for continued SARS-CoV-2 sequencing support
to study the evolving COVID-19 pandemic in our region and for our population groups.

Public health relevance
Project Narrative The goal of this project is to continue to monitor emerging variants of the SARS-CoV2 virus in Upstate South Carolina by sequencing positive samples obtained through Clemson University’s robust university surveillance and community testing programs. Variants of concern of SARS-CoV-2 have caused large outbreak events worldwide. As shown by the significant Omicron surge in the Upstate South Carolina region, this poses a serious public health threat because there is a real risk that new variants can escape the coverage of COVID-19 vaccines or infect previously exposed individuals. This sequencing project hopes to continue to provide much-needed insight and guidance to inform policy decisions to help mitigate these potential threats.